Research Supplement: Naturalistic Neuroimaging for Presurgical Language Mapping

Summary of Supplement Project
This diversity supplement to parent grant R01DC020965 “Naturalistic Neuroimaging for Presurgical Language
Mapping” (Tie, Liebenthal, PIs) seeks two years of support for graduate student Manuel Marte.
Mr. Marte is a PhD candidate in the Speech, Language and Hearing Sciences program at Boston University (BU)
and a certified speech-language pathologist with a strong clinical foundation in neuropsychological assessment
of individuals with aphasia with broad training on innovative behavioral research methods in communication
disorders. His long-term career goal is to become an academic researcher specializing in naturalistic approaches
for quantitative assessment and intervention in monolingual and bilingual persons with aphasia. Mr. Marte is of
Hispanic descent and as such, his professional and cultural backgrounds make him ideally suited for an
academic career focused on studying bilingual aphasia, and broadly, aphasia in all individuals.
The activities proposed under the supplement consist of hands-on training in naturalistic methods for aphasia
research. Mr. Marte will spearhead the development of a cutting-edge paradigm using emotional reactivity to
movie clips as a lens for assessing language capacity in aphasia. He will master state-of-the-art neuroscientific
data collection and analysis methodologies, including eye-tracking, functional MRI, and brain-lesion mapping.
He will acquaint himself with language assessment in persons with aphasia resulting from a brain tumor. The
specialized training and participation in pioneering research will lay for the applicant a robust foundation on which
to develop an independent research program.
The research activities under this supplement augment the parent grant’s Aim 1 by adding objective behavioral
(emotional reactivity) and physiological (eye gaze, fMRI) measures of language engagement to test the same
primary hypothesis, namely that language performance in individuals with aphasia will be comparable or superior
for movie-watching versus conventional language paradigms. The measures added in the supplement will be
conducted with the participants of the parent grant’s Aim 1, and do not change the risk to these participants.
Proposed for a two-year duration starting 03/15/2024, this supplement aligns with Mr. Marte’s academic timeline
(expected graduation in 02/26) and the parent grant's active period (expected until April 2028). A salient
milestone in his training trajectory includes his intent to apply for an NIH grant, such as the F32 postdoctoral
diversity fellowship grant.

Public health relevance
Narrative The scientific goal of this supplement is to develop a cutting-edge paradigm using emotional reactivity to movie clips as a lens for assessing language capacity in aphasia. More accurate measurement of language abilities in individuals with stroke-induced aphasia will facilitate the optimization of fMRI language mapping in other populations proposed in the parent grant (aphasia induced by brain tumor), and other populations in general (e.g., aphasia induced by epilepsy). Critically, if our proposed approach using implicit emotional reactivity and eye behavior as proxies for language comprehension gains empirical support, it will catalyze a substantive reevaluation in how language and cognition are assessed in persons with aphasia.